B Cell-Fibroblast Crosstalk Promotes Chronic GVHD of the Lung

ABSTRACT
This K38 award is designed to support Dr. Sonali Bracken’s research training and accelerate her path to an
independent research career in the field of autoimmunity. Dr. Bracken is a clinical rheumatologist at Duke
University with a Ph.D. in Immunology. Her long-term goal is to improve the health and longevity of patients
with autoimmune, fibroproliferative disorders through the development of B cell-targeted therapies. Through
this award, Dr. Bracken will develop expertise in the mechanisms of fibrosis, expand her proficiency in
fundamental immunological laboratory techniques, and build foundational skills in data analysis and laboratory
management. Her research progress and career development will be overseen by a multidisciplinary
mentorship team headed by both Dr. Stefanie Sarantopoulos, an expert in bone marrow transplant and B cell
signaling, and Dr. Scott Palmer, an expert in the field of lung fibrosis and transplantation. Dr. Bracken will also
benefit from a wealth of resources available through Duke University that are aimed at training physician
scientist leaders. The objective of this application is to delineate immune pathways that contribute to lung
fibrosis in patients with chronic graft-versus-host disease (cGVHD). cGVHD is a leading cause of morbidity and
mortality after allogeneic hematopoietic stem cell transplantation that results from multiorgan inflammation and
fibrosis. In up to twenty percent of patients with cGVHD, fibrosis impacts the lungs and can cause respiratory
failure. B cells are known contributors to the pathogenesis of cGVHD. The central hypothesis of this application
is that B cells and fibroblasts undergo crosstalk that leads to bidirectional cellular activation and ultimately
promotes lung fibrosis. This hypothesis will be investigated via two aims, the first of which will examine the
mechanisms by which hyperactive Toll Like Receptor 7 signaling in B cells drives fibroblast activation in the
lung. This will be accomplished through 1) co-culture assays using cGVHD patient B cells and primary human
lung fibroblasts 2) immunofluorescence microscopy in explanted cGVHD patient lung tissue samples and 3)
use of a well-characterized cGVHD mouse model that permits selective deletion of Toll Like Receptor 7
signaling pathway components in donor B cells. The second aim will examine the role of the fibroblast
extracellular matrix component hyaluronan in activating cGVHD B cells from the lung through the CD44
receptor using in vitro stimulation assays. It will also examine the differential effects of high- and low-molecular
weight hyaluronan on lung cGVHD severity using a mouse model. Altogether, these experiments are expected
to provide important insights about the role of B cells in promoting fibrosis in lung cGVHD. Ultimately, this
knowledge can be utilized to therapeutically target specific points of B cell-fibroblast crosstalk that are critical
for promoting fibrosis in cGVHD. It is likely that the knowledge gained from this proposal will also be relevant to
mechanisms that drive lung fibrosis in autoimmune connective tissue disease. Furthermore, this proposal will
position the candidate to submit a K08 Career Development Award during the final year of the award period.

Public health relevance
PROJECT NARRATIVE Inflammation and scarring of the lung is a leading cause of death among patients with autoimmune disorders, but efforts to reduce the mortality burden of this condition have been limited by a lack of effective anti-fibrotic treatments. The proposed research will define B cell-mediated pathways that contribute to the development of pulmonary fibrosis in patients with chronic graft-versus-host disease (cGVHD), an autoimmune-like condition that occurs in patients who undergo allogeneic stem cell transplantation. Knowledge gained from this study will accelerate the development of targeted immune therapies to improve the lives of patients with cGVHD and autoimmune lung disease while simultaneously fostering the career of a physician investigator committed to an independent research career in immunology.